Enhancing PTSD Treatment Outcomes by Improving Patient-Provider Communication

Project Summary/Abstract
Posttraumatic stress disorder (PTSD) is a debilitating condition with deleterious effects on individuals and
society. Evidence-based treatments for PTSD are available, including cognitive processing therapy (CPT) and
prolonged exposure (PE), but response rates are suboptimal, and dropout rates are high. Patients report
concerns about treatment that prevent optimal response, but evidence suggests therapists are often unaware of
patients' concerns and do not intervene effectively to help their patients benefit from treatment. The purpose of
this research is to refine and test an Adjunctive Writing intervention for Amplifying Response and Engagement
(AWARE), which was developed to enhance outcomes in CPT and PE. AWARE integrates findings from the field
of health communication and uses a writing task and guided therapist responses to facilitate improved patient-
therapist communication about patients’ treatment-related concerns during existing check-ins in CPT and PE.
After iteratively refining AWARE through a case series (n=4), a pilot randomized controlled trial (n=50) will be
conducted to preliminarily compare CPT/PE with AWARE to CPT/PE treatment as usual (TAU). The primary aim
of the RCT is to take an experimental therapeutics approach to demonstrate that AWARE is feasible, acceptable,
and engages the target of improved patient-therapist communication relative to TAU. A preliminary examination
will also be conducted of the effects of 1) AWARE vs. TAU, and 2) variability in patient-therapist communication
on symptom improvement and treatment completion. An exploratory aim is to examine patient-therapist
communication as a mechanism of improved symptom reduction and attendance in AWARE using session-by-
session assessments to see if the putative mechanism precedes and predicts the outcomes. This trial is
consistent with NIMH's Strategy 3.1.A, "Developing novel interventions using a mechanism-informed,
experimental therapeutics approach," and can both enhance outcomes for patients with PTSD and improve the
field's knowledge of processes for enhancing PTSD treatments. Further, given that AWARE is a brief intervention
that can be implemented during existing check-ins in evidence-based treatments, AWARE can be easily scaled
and implemented to enhance outcomes across mental health disorders. The proposed research and training
plans will allow the applicant to gain essential knowledge and applied experience in 1) refining and evaluating a
mechanism-based intervention to enhance PTSD treatments, 2) translating health communication knowledge to
improve PTSD treatment outcomes, 3) using advanced data analyses to examine mechanisms of therapeutic
change, 4) conducting clinical trials in an experimental therapeutics framework, and 5) professional development
and grantsmanship. It will facilitate the applicant's transition to an independent investigator who uses treatment
mechanistic knowledge to optimize PTSD treatment outcomes. This project will take place at the National Center
for PTSD at VA Boston Healthcare System with support from accomplished mentors committed to the applicant's
professional development: Drs. Tara Galovski (primary mentor), Shannon Kehle-Forbes, and Brian Smith.

Public health relevance
Project Narrative Evidence-based treatments for posttraumatic stress disorder (PTSD) are available, but they have suboptimal rates of symptom improvement and high rates of dropout, and evidence suggests that patients' concerns about treatment and therapists' ineffective responses to these concerns prevent optimal outcomes. This trial tests an Adjunctive Writing intervention for Amplifying Response and Engagement (AWARE), which integrates findings from the health communication literature to optimize patient outcomes in evidence-based PTSD treatments via the target mechanism of improved patient-therapist communication about patients' treatment-related concerns. This trial has the potential to enhance outcomes for patients with PTSD and improve the field's knowledge of processes for enhancing PTSD treatments, and further, given that AWARE is a brief intervention that provides structure for improving patient-therapist communication during existing check-ins in evidence-based, widely disseminated treatments, AWARE can be easily scaled and implemented to enhance patient outcomes in treatments across mental health disorders.